Mapping and Modeling Chemotaxis Protein Interactions

DESCRIPTION (provided by applicant): I propose to study and model the protein-protein interactions that underlie sensory-motor regulation in motile cells such as E. coli and S. typhimurium. These cells chemotax towards attractants and away from repellents. The mechanism for this behavior involves membrane spanning chemoreceptors that regulate a histidine kinase, CheA, to control the phosphorylation of the response regulator, CheY. Phospho-CheY binds the flagellar motor proteins to change the direction of swimming. It is now known that the chemoreceptors and other components of this system are localized to a small patch near one pole of the cell. I propose first, to understand better using fluorescence resonance energy transfer and molecular modeling the interactions that exist between the chemoreceptors CheA, and CheW; second, to similarly determine where CheA and CheW interact, and whether they interact in the absence of the chemoreceptors; and third, to develop an information theoretical model to understand the information transmission and processing capabilities of the chemotaxis system. In addition to the general significance of the chemotaxis system to transmembrane receptor signaling, the underlying mechanism provides a model for understanding homologous two-component systems that mediate adaptations to environmental perturbations ranging from cell cycle regulation to fruiting body development and sporulation in bacteria and a range of other organisms.